CAGT Shared Instrumentation Grant: IncuCyte SX5 Imaging System

PAR: 22-080 S10 Biomedical Research Support Shared Instrumentation Grants
CAGT Shared Instrumentation Grant: IncuCyte SX5 Imaging System
Project Summary/Abstract
The development of cell and gene therapies to target cancer has revolutionized the approach to treat patients
with blood cancers. However, this treatment has had little effect on the treatment of solid tumors which comprise
about 90% of all cancers. Therefore, novel strategies to develop therapies must be considered and
multiparametric evaluation of those products are critical to understand their functionality. Utilizing state-of-the-art
technology such as live-cell image analysis in complex models will provide improved accuracy and consistent
testing of current and future products that will translate to the treatment of patients.
We aim to purchase a new IncuCyte SX5 with funds provided through the Shared Instrument Grant application
that can be used in the Center for Cell and Gene Therapy (CAGT). The IncuCyte is a live cell imaging system
that allows easy quantification of cell morphology and behavior over time. The SX5 provides up to five color
fluorescent imaging with the capability of three-color multiplexing compared to the current two-color fluorescence
with the S3 model. This instrument improves productivity by allowing automatic acquisition and analysis for up
to six culture plates or vessels in parallel. Analyses include the visualization and quantification of cell proliferation,
tumor and immune cell interactions, cytotoxicity, cell type specific metabolic activity, and three-dimensional tumor
spheroid assays. The SX5 increases the flexibility of experimental parameters and reagents when evaluating
complex therapies developed by investigators at CAGT. Novel evaluations with the IncuCyte SX5 will prove to
be invaluable to assess the functionality of cell and gene therapy products for clinical translation.

Public health relevance
PAR: 22-080 S10 Biomedical Research Support Shared Instrumentation Grants CAGT Shared Instrumentation Grant: IncuCyte SX5 Imaging System Project Narrative To improve the development of new therapies to target cancer, state of the art testing must be completed to understand how these treatments work in complex models. Using live-imaging offered by automatic instruments, such as the IncuCyte SX5, will provide high throughput information on how novel therapies work and ultimately improve patient outcomes.